Deranged Gut Homeostasis and the Pathogenesis of Fibromyalgia

Fibromyalgia (FM) is a chronic debilitating painful condition, affects millions of people in the U.S. alone, and is
often refractory to the current treatment. The etiology of FM is multifactorial in which deranged gut homeostasis
has been strongly implicated. Up to 70% of FM patients exhibit signs of deranged gut homeostasis, highlighting
a key gastrointestinal component in the pathogenesis of FM. To date, the molecular link between deranged gut
homeostasis and FM is poorly understood. The gut brush border enzyme intestinal alkaline phosphatase (IAP),
encoded by Akp3 gene in mice and Alpi gene in humans, is a critical regulator of gut homeostasis. We and others
have reported that knockout of Akp3 (Akp3-/-, IAP deficiency) in mice disrupts gut homeostasis with increased
gut and systemic inflammation markers. Our preliminary data demonstrate that a) Akp3-/- mice recapitulated FM-
like phenotypes including i) hypersensitivity to mechanical and thermal stimulation, ii) spontaneous pain behavior,
and iii) FM-related comorbid behaviors including depression and anxiety; b) administration of exogenous
recombinant IAP reversed IAP deficiency and improved FM-like phenotypes in Akp3-/- mice; c) macrophages
and transient receptor potential vanilloid 1 (TrpV1) expression were increased in the dorsal root ganglion (DRG)
of Akp3-/- mice; and d) IAP levels were reduced in stool samples of FM patients as compared to healthy subjects.
These findings suggest that IAP could be a key molecule link between deranged gut homeostasis and the
pathogenesis of FM. We propose that deficiency of Akp3-encoded IAP would lead to FM-like phenotypes through
macrophage-mediated sensitization of TrpV1 positive (TrpV1+) nociceptors in the DRG. In Aim 1, we will test the
hypothesis that IAP deficiency induces macrophage infiltration into the DRG and FM-like phenotypes. We will
examine i) macrophage infiltration into the DRG using flow cytometry, immunostaining, and two-photon imaging
with an innovative in vivo DRG window technique to correlate with FM-like phenotypes; ii) the effect of reversing
IAP deficiency with exogenous recombinant IAP on macrophage infiltration into the DRG and FM-like
phenotypes; and iii) the relationship between IAP deficiency-induced deranged gut homeostasis and DRG
macrophage infiltration. In Aim 2, we will test the hypothesis that macrophage infiltration into the DRG plays a
critical role in FM-like phenotypes. Genetic and pharmacological approaches will be used to i) deplete systemic
vs. DRG macrophages; ii) inhibit monocyte/macrophage trafficking; and iii) suppress inflammatory macrophages.
In Aim 3, we will test the hypothesis that TrpV1+ nociceptors in the DRG are sensitized via macrophage-
nociceptor interactions in mice with FM-like phenotypes. We will i) inhibit TrpV1 genetically (TrpV1DTR) or
pharmacologically and ii) examine a macrophage-mediated signaling in sensitization of TrpV1+ nociceptors using
an innovative DRG calcium imaging platform, TrpV1::ChR2 mice, and patch clamp recording. This project will
provide insights into a novel molecular mechanism of FM pathogenesis and help transform the current treatment
limited to managing FM symptoms to mechanism-based therapy for FM patients with deranged gut homeostasis.

Public health relevance
Project Narrative Fibromyalgia (FM) is a chronic debilitating painful condition, affects millions of people in the U.S. alone, and is often refractory to the current treatment. This grant project will examine a novel molecular mechanism of FM pathogenesis. The outcomes of this project will help transform the current treatment limited to managing FM symptoms to mechanism-based therapy for a large population of FM patients.